Designing belonging: Advancing science on environmental modifications to foster activity engagement and social connection among individuals with serious mental illness

ABSTRACT
People with serious mental illness (SMI) experience dramatically worse health and longevity than the
general population, which is exacerbated by extremely high rates of loneliness and social isolation. Both social
isolation (lack of social supports) and loneliness (the subjective experience of isolation) are highly predictive of
early mortality. Although social isolation and loneliness are inherently relational, influenced by contextual
factors, and prevalent among people with SMI, very little is known about how to design community mental
health environments that foster social connection (“social architecture”). Thus, the goal of this K01 is to lay the
foundation for an innovative, impactful research career focused on reducing social isolation among people with
SMI through environmental design. My research plan employs a rigorous, mixed-method design to: 1) identify
environmental features associated with two behavioral mechanisms of action: activity engagement and social
interaction; 2) examine associations between activity engagement, social interaction, and self-reported
loneliness and support; and 3) feasibility test the co-design and implementation of an environmental
modification to support social connection. To do this, I will first conduct socio-spatial observations of activity
engagement and social interaction in four mental health Clubhouses in Hawaii. These are community-based
psychosocial rehabilitation centers that are highly interested in reducing loneliness among their members.
Observation data will be paired with survey data (N=150) to examine associations between observed activity
engagement and social interaction and self-reported loneliness and social support. Second, spatial
observations and social network data will be visualized to refine a conceptual model interlinking engagement
and social interaction. These visualizations will be shared with participating Clubhouses to contextualize the
identified patterns in engagement and social interaction and to co-identify potentially modifiable environmental
features associated with them. Third, an environmental intervention co-design process will be conducted in one
Clubhouse and the intervention will be implemented. Feasibility data on the co-design process and
modification of the environmental intervention protocol will be collected through field notes and a final focus
group and subsequently analyzed qualitatively. This research will be carried out with close mentorship from a
team of highly accomplished senior scholars: Drs. Henwood, Wenzel, Salzer, Valente, Wilson, and Stark. Their
work is directly aligned with my career and training goals, which focus on three intersecting areas of expertise:
1) socio-spatial methods (GIS, social network analysis and ecological momentary assessment), 2) theory
linking environmental design, human behaviors, and health, and 3) environmental intervention co-design based
on community-based participatory research principles. This K01 builds on my unique clinical and theoretical
background as an occupational therapist and community psychologist and lays the foundation for an
innovative, highly impactful career focused on reducing social isolation and loneliness among people with SMI.

Public health relevance
PROJECT NARRATIVE Individuals with serious mental illness (SMI) experience unconscionable disparities in health and longevity, which are exacerbated by social isolation and loneliness. The objective of this career development award is to build the foundation for a unique program of research focused on how behavioral mechanisms of action (social interaction and activity engagement) can reduce social isolation among people with SMI through targeted, co-designed environmental modifications in community mental health centers. This will be achieved through an innovative, stepwise, mixed- methods research plan integrated with world-class mentorship and training in: (1) socio-spatial methods (GIS, social network analysis, and ecological momentary assessment); (2) theory interlinking environmental design, behavior and health; and (3) intervention co-design based on community-based participatory research principles.